Defining cardinal functions of lung progenitors during regeneration

PROJECT SUMMARY
The respiratory system is constantly exposed to environmental insults, requiring robust mechanisms for repair
and regeneration. However, the impact of acute lung injury on cell lineage behavior, both in the short and long
term, remains poorly understood, particularly in the context of chronic lung diseases like chronic obstructive
pulmonary disease (COPD) and idiopathic pulmonary fibrosis (IPF). This research aims to address how acute
injury disrupts tissue homeostasis and contributes to long-term pathological changes that affect lung
regeneration. We have utilized a multi-modal approach to investigate the short- and long-term consequences of
viral injury on the respiratory system. Our methods include cell type-specific lineage tracing, pulsed single-cell
analysis, histological spatial analysis, and cross-species comparison with a unique human lung disease biobank.
These data have been integrated with temporal cell fate mapping to record stem and progenitor cell responses,
including proliferation and differentiation after injury. Our findings reveal that progenitor cells within the alveolus
respond in a uniquely phased manner: the immune system reacts first, followed by epithelial and mesenchymal
progenitors, and finally endothelial progenitors. We identified persistent changes in specific progenitor lineages
and overall our studies highlight the importance of progenitor proliferation in lung regeneration, revealing that
loss of progenitor activity leads to varying outcomes, such as emphysema or improved regeneration, depending
on the affected lineage. These findings support the hypothesis that acute lung injury induces persistent
alterations in progenitor cell behavior, including altered proliferation. We propose that the loss of this proliferative
capacity leads to unpredictable phenotypes in lung regeneration, resembling those seen in human lung diseases.
This work lays the foundation for future studies aimed at developing targeted therapies to restore progenitor
function and improve lung regeneration after injury.

Public health relevance
NARRATIVE Acute lung injury disrupts progenitor cell behavior, with lasting impacts on tissue regeneration and disease progression in chronic conditions like COPD and IPF. Our proposal uses multi-modal approaches to map stem/progenitor cell responses to viral injury, revealing unique phases of proliferation and differentiation in alveolar progenitors and suggest that loss of progenitor proliferation leads to unpredictable regeneration outcomes and may contribute to long-term pathological states, such as fibrosis or emphysema.